ALLOPURINOL AND PREVENTION OF DEATH, TISSUE INJURY AND SEIZURES IN CHD

To determine if pretreatment with allopurinol reduces the risk of death, coma, or seizures in infants with congenital heart disease.